CRF BINDING PROTEIN AND DEMENTIA

DESCRIPTION (Adapted from applicant's abstract): Corticotrophin releasing factor(CRF) has been implicated in cognitive function and neurological illness such as Alzheimer's disease (AD). Evidence includes large decreases in CRF and up-regulation of CRF receptors in brain areas affected in AD. The benefits of postsynaptic CRF agonist therapy may be outweighed by the anxiogenic side effects of CRF. A membrane associated CRF binding protein with a high affinity for CRF and an ability to inactivate CRF has been identified in brain areas associated with AD. Antagonists of CRF-BP may offer a novel means of increasing synaptic CRF in selective brain areas without the side effects that would occur with a postsynaptic receptor agonist. The proposed studies quantify CRF and CRF-BP in postmortem brain samples in AD and age-matched controls; evaluate the cognitive enhancing effects of CRF-BP in animal models of learning, memory and anxiety; and identify non-peptide leads at the human CRF-BP. The second phase of the proposal will involve optimization of the small molecule CRF-BP leads through a directed chemical synthesis program in order to identify novel orally active drugs for cognitive and neuronal deficits seen in AD.